Establishing an Advanced Microscopy and Diagnostic Research Facility for the Midwest and Illinois MSI Alliance

Project summary/abstract
The University of Illinois Urbana-Champaign (Illinois) proposes to expand its Microscopy Core Facilities to
establish an Advanced Microscopy and Diagnostics Facility to create a regional center for sophisiticated
microscopy instruments, a facility to develop and test diagnostics tools to detect circulating biomarkers, and a
clinical research suite for sample collection. By doing so, this facility, located in a premier interdisciplinary
research institute, the Carl R. Woese Institute for Genomic Biology (IGB), will provide a centralized location for
Illinois campus researchers, regional partners in universities, non-profits, and companies to have access to tools
and instrumentation that help address important research topics including cancer, neurodegenerative diseases,
and women’s health. Importantly, it will reduce the burden on smaller institutions to obtain high-end instruments
and will increase collaboration across Illinois and the Midwest. The clinical research suites will provide added
capacity on the Illinois campus to meet the clinical research needs, and the diagnostics lab will provide a shared
central location for the scattered labs across campus. The current microscopy facility has exceeded capacity
limits, and instruments are housed suboptimally in shared or repurposed rooms. The proposed remodeling will
focus on a targeted expansion to accommodate the three above needs to increase capacity for biomedical
research. The 4830 sq. ft. expansion requires renovating an existing space and new construction of an
undeveloped space north of the IGB. The IGB’s central location on campus is particularly beneficial for Illinois
trainees and post-docs, offering them 24/7 access and proximity to the expanded facilities. Our goal is to increase
access and establish Illinois as a Midwest hub for advanced microscopy by providing best-in-class training with
state-of-the-art equipment to better enable biomedical researchers to address research grand challenges, both
within our university and across a diverse set of regional partners.